Mathematical modeling to optimize rotavirus vaccination in sub-Saharan Africa

Rotavirus is the leading cause of childhood diarrheal disease, responsible for an estimated 146,000 annual
deaths across the globe. A large majority of these deaths occur in low-resource settings where life-saving
rehydration therapy is often inaccessible. A challenge to mitigating this burden arises from the reduced efficacy
and durability of rotavirus vaccines observed in low-resource settings compared to high-resource settings.
Proposed explanations include the higher force of infection in these settings, host factors such as poor nutrition
or intestinal co-morbidities, and interference from maternal antibodies or the concomitantly administered oral
poliovirus vaccine. These mechanisms may not be mutually exclusive. Depending on the contribution of each
potential factor, optimization of the vaccination schedule, through addition of an age-based booster dose, a
seasonal booster, or a delay in the initiation of the primary vaccine series, could improve vaccine protection.
Each proposed schedule change carries advantages and trade-offs. An age-based booster would have
straightforward roll-out within existing infrastructure, while a seasonal booster may have greater impact on
incidence. Seasonal boosters may be particularly effective if maternal antibody interference is heightened for
infants born during or following the peak of the rotavirus season. Delayed series initiation could improve
vaccine protection for older infants, but may extend the period during which infants are susceptible to primary
infection. To inform policy development based on these potential interventions, mathematical modeling and
cost-effectiveness analyses are tools to evaluate their relative epidemiological and economic impacts. I will use
data-driven mathematical modeling to optimize the rotavirus vaccination strategy for Mali based on anticipated
health benefits and associated costs, through the following aims:
(1) Characterize seasonal variation in maternal and infant antibody titers. Using pairs of mother
and infant sera collected by CVD-Mali prior to rotavirus vaccine introduction, I will compare titers during high
and low exposure seasons to identify differences in anti-rotavirus IgA and rotavirus neutralizing antibody levels.
(2) Analyze rotavirus vaccine efficacy and waning. I will build a dynamic rotavirus transmission
model explicitly parameterized and validated for the Malian context. Among other key factors, I will incorporate
any seasonal trends in maternal antibody interference identified in Aim 1.
(3) Optimize rotavirus vaccination schedule. Applying the transmission model developed in Aim 2, I
will compare severe rotavirus incidence under the status quo three-dose (primary) schedule against four
proposed schedule changes: delayed primary series initiation, introduction of a booster for 9-month-olds,
seasonal booster for children aged 6 through 18 months, and the replacement of the third primary dose with a
dose for older children. I will incorporate programmatic and disease costs to predict the cost-effectiveness of
each strategy and identify the optimal schedule from both societal and individual perspectives.

Public health relevance
Narrative Rotavirus causes over 146,000 deaths each year, and unfortunately protection from rotavirus vaccines appears to be reduced in the low-resource settings where most of these deaths occur. My proposed research will examine potential causes of this reduced protection in Mali, and then compare the expected health and economic impact of vaccine schedule changes on rotavirus disease. Results will be communicated to policymakers in Mali and to international public health decision-makers, providing an evidence base for the optimal rotavirus vaccination schedule in Mali and throughout sub-Saharan Africa.